INTESTINAL PERMEABILITY OF RANITIDINE IN HUMANS

An intestinal perfusion study will be conducted to determine intrinsic effective intestinal wall permeability of ranitidine and correlate the fraction of dose absorbed and dimensionless effective permeability (Peff*) in human subjects by using a modified boundary layer analysis. The intraindividual variability estimated during on experimental day will also be investigated.